Anatomic, Pathologic, and Molecular Signatures of FTLD-TDP type C

ABSTRACT.
Neurodegenerative diseases can have common, uncommon, and idiosyncratic manifestations. In contrast,
frontotemporal lobar degeneration with transactive response DNA-binding protein type C (TDP-C) shows a
consistent and prolonged predilection for the anterior temporal lobe, a region critical for word comprehension on
the left-sided hemisphere and non-verbal semantics (e.g., object recognition, contextualization of conduct) on
the right. During the past 15 years, the Northwestern Primary Progressive Aphasia (PPA) Research Program
has recruited one of the world’s largest cohorts of TDP-C cases. Each case has been deeply-phenotyped and
longitudinally imaged and 25 have come to autopsy. In the course of these investigations, we have made
important discoveries that have led to a theoretical overview of TDP-C, its distinctions from other forms of FTLD-
TDP, its remarkable affinity for the anterior temporal lobe, and its impact on the fundamental process of language
comprehension. These studies have raised new questions about TDP-C neuropathology. The current proposal
aims to expand on these discoveries in ways that go beyond PPA by encompassing other clinical manifestations
of TDP-C, their corresponding hemispheric asymmetry patterns, their distinctive impact on local cortical circuitry,
and their relationship to the molecular fingerprints of the anterior temporal lobe. This proposal will benefit from
synergies with the overall PPA program and the Northwestern ADRC and will, in turn, enrich both programs. The
proposal revolves around three aims. Aim 1 will investigate the neuropathological concordance of TDP-C
neuropathology with the asymmetric atrophy patterns seen in PPA versus other major neurobehavioral
syndromes, each with a distinct pattern of asymmetric progression. Aim 2 will focus on the microcircuitry of
these concordance patterns, namely the impact on inhibitory neurons and the laminar distribution of
neurosynaptic perturbations. Aim 3 will address the transcriptomic patterns that potentially earmark the anterior
temporal lobe for special vulnerability to TDP-C in each syndrome, each with different asymmetries of
vulnerability. Although TDP-C is a relatively rare disease it offers unprecedented opportunities for understanding
the general biologic mechanisms of selective vulnerability in neurodegenerative disease. An additional
consequential outcome would be to discover druggable protein targets that interfere with the destructive effect
of TDP-C on the anterior temporal lobes.

Public health relevance
PROJECT NARRATIVE. A central challenge in the field of neurodegenerative disorders concerns the correspondence between features of dementia and molecular pathology. The proposed work aims to identify and examine the anatomic, pathologic, neurobiologic, and molecular signatures of the type C variant of FTLD-TDP, a proteinopathy that shows a remarkable affinity for the anterior temporal lobe, a brain region critical for complex cognitive and behavioral functions. This specificity offers unprecedented opportunities for clarifying broader principles of disease propagation and selective vulnerability and is highly relevant to the future development of protein-specific biomarkers and therapeutic targets.